Target Engagement and Clinical Symptom Change with a FAAH Inhibitor for Posttraumatic Stress Disorder

There is an urgent need for mechanism-based novel pharmacological approaches to treat trauma-related
disorders such as posttraumatic stress disorder (PTSD), as 40-60% of patients do not respond to current
pharmacological or behavioral therapies. High heterogeneity of symptom patterns and trajectories in PTSD
suggests alterations in multiple neurobiological systems. Negative valence processing and arousal in response
to affective stimuli (AS) and conditioned fear stimuli (CFS) have been proposed as translational multi-level
processes within the NIMH Research Domain Criteria (RDoC) that are relevant to trauma and other stress-
related disorders. Reliable disruptions have been observed in the functioning of brain systems that regulate AS
and CFS reactivity in individuals with PTSD. A class of medications acting on the endocannabinoid system,
inhibitors of fatty acid amide hydrolase (FAAHi) are hypothesized, based on a large body of preclinical
research, to modulate activity in AS and CFS regulatory systems (e.g., enhancement of fear extinction). FAAHi
may therefore offer clinical benefit for patients with PTSD—and trans-diagnostically for other anxiety and
stressor-related conditions—who show consistent dysfunction in those circuits. The proposed project evaluates
the ability of a FAAHi developed and characterized by Janssen, JNJ-42165279, to engage systems that
regulate AS (e.g., amygdala activation during emotion face processing; primary target) and CFS (e.g., fear
extinction; secondary target) in the service of reducing hyperarousal (primary clinical outcome) and re-
experiencing symptoms (secondary outcome). The project aims are supported by extensive preliminary data in
healthy humans indicating that JNJ-42165279 dose-dependently inhibits FAAH as evidenced by dose-
dependent increases in plasma anandamide; saturation of FAAH (>80%) is achieved at doses that have no
clinically significant adverse effects in humans; and once steady state is achieved, AS and CFS reactivity is
attenuated. Based on these observations, we propose a two-site, randomized double-blind fixed dose (25 mg
BID) placebo-controlled trial of JNJ-42165279 in N=150 patients with PTSD. Aim 1 seeks to confirm target
engagement through reduced amygdala activation during AS processing (primary target) as well as reduced
physiological and subjective CFS reactivity during exposure to a trauma narrative and fear extinction recall
(secondary targets) from baseline to steady state (5 days of treatment). Aim 2 will test the hypothesis that
attenuation of amygdala reactivity from baseline to Day 5 in the JNJ-42165279 group will be associated with
symptom change from baseline to week 8. We will explore links between changes in secondary measures of
target engagement (trauma-specific arousal reactivity and fear extinction recall) and changes in hyperarousal
and re-experiencing symptoms at 8 weeks. If these predictions are confirmed, this project will support future
studies of FAAHi (and other drugs with similar mechanisms of action) in definitive, larger randomized controlled
trials for PTSD and other anxiety and stressor-related conditions with dysfunction in AS and CFS domains.

Public health relevance
Project Narrative Posttraumatic stress disorder (PTSD) can affect as many as 1 in 10 people in the U.S., yet there have been no new medication-based treatments for this condition over the past 20 years. This proposal capitalizes on recent experimental and clinical findings to determine whether a new medication that acts upon brain systems that influence our stress responses might be an effective treatment for PTSD. We will examine whether this medication changes arousal and threat reactivity, and if so, whether those changes are associated with reductions in posttraumatic stress symptoms, thereby validating a potential new treatment approach for PTSD and other stress-related conditions.